Molecular Mechanism of an Exporter-like ABC Importer YbtPQ

Bacterial infections pose one of the most significant global public health challenges, exacerbated by the
emergence of antibiotic-resistant strains. As a result, treating these infections has become increasingly difficult.
Recently, the FDA approved cefiderocol, a siderophore-antibiotic conjugate, as a new treatment for urinary tract
infections (UTIs) caused by antibiotic-resistant Gram-negative bacteria. This approval highlights the potential of
targeting the bacterial siderophore-mediated metal uptake process for pharmaceutical interventions. A crucial
step in this process involves the uptake of metal-chelated siderophores across the bacterial inner membrane,
facilitated by ATP-binding cassette (ABC) importers. Unfortunately, the detailed molecular mechanisms
underlying these importers remains poorly understood, impeding the development of targeted drugs. This
proposal focuses on a unique example of these critical importers: the yersiniabactin importer YbtPQ from
uropathogenic E. coli, the leading cause of UTIs. Our preliminary studies have revealed that YbtPQ exhibits
folding characteristics similar to an ABC exporter, representing a novel type of ABC transporter. Building upon
this discovery, we expect to study the fundamental structure-function relationship of YbtPQ by pursuing two
specific aims: 1) Define the substrate selectivity and inhibitory mechanism of YbtPQ; 2) Understand the unique
structural motifs within YbtPQ. To accomplish these goals, we will employ a multidisciplinary approach,
combining mutagenesis, specifically-designed transport assays, microscale thermophoresis, circular dichroism,
native mass spectrometry, molecular dynamic simulations, and cryo-electron microscopy. Successful completion
of this proposal will yield valuable insights into the substrate/inhibitor selectivity and transport dynamics of YbtPQ.
This knowledge will serve as a solid foundation for future drug development targeting this importer, offering new
possibilities for effectively treating bacterial infections and addressing the challenges of antibiotic resistance.

Public health relevance
The proposed research is relevant to public health because it seeks to improve our understanding of the siderophore-mediated metal uptake process in uropathogenic E. coil, the leading cause of urinary tract infections. It will provide a concrete knowledge foundation for developing drugs to battle bacterial infections, which is relevant to the NIH’s mission.